Systems and Integrative Biology Training Program

Abstract:
Our proposed Systems and Integrative Biology training program will support cross-disciplinary training in
quantitative and systems approaches for students across the basic science PhD programs the University of
Michigan Medical School. An overarching goal of the proposed program is to prepare participating PhD
students with the broad knowledge, understanding, and insight into quantitative and systems approaches that
will be necessary for them to readily adopt and adapt emerging technologies throughout their careers. Beyond
simply providing training in specific computational methods or software tools, this training program seeks to
achieve this broader goal by targeting a number of innovative objectives, including providing unique resources
for career developing, building collaborative networks, delivering dynamic flexible training in quantitative and
computational methods, and a flexible portfolio-based approach to tracking and demonstrating individual
progress. Moreover, the program proposal describes an innovative approach to disseminating resources
developed under this program, to substantially magnify the impact of this SIB training program beyond its
impact on the relatively few trainees and mentors enrolled in the program. These, and other defining objectives
of the SIB program will be achieved through a number of initiatives and activities that will facilitate SIB trainees
to conduct and communicate leading-edge integrative research in a multidisciplinary setting. These activities
and initiatives include formal requirements such as a course curriculum, mentor training, development of
individual development plans, and a training and program assessment, as well as monthly workshops that
bring together faculty mentors, current and past trainees to present and discuss works in progress, present
questions, propose and demonstrate solutions, teach one another, and work together on current research
problems. The ultimate goal of our program is for SIB trainees to be highly sought-after to fill rewarding
positions in academia, industry, and government laboratories, as well as a variety of non-traditional careers
where their training gives them the skills to excel in areas of educational leadership, science communication,
patent law, translational medicine, and science policy.

Public health relevance
We are seeking funding to support a unique and innovative PhD training program for cross-disciplinary training in quantitative and systems approaches in biomedical science. Primary objectives of the program include for trainees to attain and demonstrate quantitative and systems analysis skills, to facilitate the establishment of collaborative research networks, and to broadly disseminate innovative training and research tools.